Beyond Pseudotime: Enhanced Single-cell Genomics Tools for Understanding the Temporal Dynamics of Development and Disease

ABSTRACT
From a single fertilized egg, the human genome must regulate an incredible succession of cellular divisions and
fate decisions to give rise to the adult human body and its ~30 trillion cells [1]. The genome must also orchestrate
highly diverse functions in these terminal cell types and in many instances allow for dynamic responses to a
variety of stimuli - from white blood cells responding to stimulation [2] to hepatocytes responding to hormonal
cues [3]. Furthermore, developmental processes are asynchronous and continue for many cell types into
adulthood. Fundamental to our understanding of the causal links in all of these processes is the concept of time.
While time course studies have a long history in genomics [4], single-cell genomic technologies are providing
unprecedented views into the temporal dynamics of cellular differentiation and response at a genomic scale [5].
This will have widespread implications for our strategies of stem cell therapy, windows of intervention in disease
progression, and our basic understanding of developmental biology. However, these inferences are to-date
limited and rely on a concept called ‘pseudotime’ [5], which is difficult to validate and can be warped relative to
real time. To truly understand how the genome coordinates development, differentiation, and disease we need
new tools that allow us to better measure several key features of developmental trajectories: the ordering
of regulatory cascades, the duration of the key genomic events in developmental processes, and the
specific DNA sequences that can regulate temporal expression patterns. In order to address these
concerns, we will develop a new suite of tools that leverage single-cell readouts to better understand the
genomic regulation of time. In particular, we will focus on highly multiplexed assays to better understand the
necessary and sufficient ordering of regulatory cascades in differentiation pathways, assays to convert
pseudotime to real time, and genome scalable assays to identify and validate the exact regulatory
sequences that define temporal patterns of gene expression.

Public health relevance
NARRATIVE Single-cell genomics are helping to reshape our understanding of human development and identify pathogenic cell types in a variety of settings. The work proposed in this application will improve single-cell technologies so that they can more accurately measure time. This will potentially have widespread implications for public health, including leading to improved stem cell treatments, better understanding of intervention time windows, and more targeted gene therapies.